Leveraging innate immunity for GIST therapy

Project Summary/Abstract
While imatinib remains the gold standard for systemic therapy in gastrointestinal stromal tumors (GISTs),
the vast majority eventually progress while on treatment and some patients present with resistant tumors.
While novel immunotherapies have shown potential in preclinical models, they have yet to demonstrate
significant clinical efficacy alone or in combination with tyrosine kinase inhibition. Tumor associated
macrophages (TAMs) have been shown to be essential in antitumoral immunity in GIST, and there is
evidence that their activation can synergize with imatinib therapy. Dectin-1 is a pattern recognition receptor
(PRR) present on TAMs originally described for its ability to stimulate an immune response to fungal
pathogens. Activation of dectin-1 on TAMs and dendritic cells (DCs) has been shown to stimulate
antitumoral immunity in some preclinical models of solid tumors but there are discrepant results. We found
that dectin-1 is highly expressed on TAMs and DCs in a genetically engineered mouse model of GIST, as
well as TAMs from human GISTs, regardless of imatinib treatment status. Dectin-1 appears to be largely
restricted to M1-like TAMs and DCs, as opposed to tumor cells or other immune cell types. As such, we
hypothesize that dectin-1 activation will cause GIST regression via TAMs and DCs and this effect will be
augmented by imatinib therapy. Since dectin-1 likely works via immune cells, it will be therapeutic in
imatinib-resistant GIST. We will study to role of dectin-1 in the immune response to GIST by performing
flow cytometry, RNA seq, and in vitro functional experiments on TAMs and DCs derived from mice treated
with vehicle or d-zymosan, a specific dectin-1 agonist. Furthermore, we will isolate TAMs and DCs from
mouse and human GISTs and culture them with d-zymosan to determine its direct effects. To determine
the anti-tumor efficacy of dectin-1 activation in our mouse model, we will assess tumor size, histology, and
KIT signaling after d-zymosan administration. The combination of dectin-1 activation and tyrosine kinase
inhibition will be tested in imatinib-sensitive and imatinib-resistant mouse models. The mechanism of
dectin-1 activation will be elucidated by depleting TAMs or DCs. The work will take place in the well-
established lab of Dr. DeMatteo, a world leader in GIST research, and exemplary surgeon-scientist at the
University of Pennsylvania. The fellowship will include immersion in a collaborative and dynamic lab
environment, regular seminars, attendance at national conferences, and mentoring of medical and
undergraduate students.

Public health relevance
Project Narrative This project will contribute to the scientific community’s understanding of how the human body’s immune system helps protect against gastrointestinal stromal tumors, a type of lethal tumor arising from the connective tissue of the gut. More importantly, however, it will uncover how we can stimulate the immune response to target these tumors. This has the potential to improve systemic therapy when given in combination with imatinib, the gold standard drug, as well as open the door to new treatment options for imatinib-resistant disease.